A proteomics atlas of HIV/HBV infections for curing HBV

Project Summary
Hepatitis B virus (HBV) infections affect the lives of more than 296 million people who are chronically infected
with HBV and are at risk of developing liver cirrhosis and hepatocellular carcinoma. Every year approximately
820,000 people die due to HBV-related complications and currently there is no effective cure. At the same time
human immunodeficiency virus (HIV) infects about 38 million people worldwide. Among those, 7.4% globally and
15-28% in highly endemic areas are also infected with HBV. HIV/HBV co-infected individuals are at higher risk
to develop severe liver disease and liver cancer than HBV mono-infected people with mechanisms that are not
well understood.
Chronicity of HBV infections is linked to the stability and maintenance of the covalently closed circular DNA
(cccDNA), which is the nuclear form of the HBV genome. The goal for a functional HBV cure relies on strategies
that will either eliminate or inactivate the cccDNA. Therapies that are based on nucleoside analogs do not target
the cccDNA while the mechanisms by which IFNα blocks HBV replication are not entirely understood in respect
to the direct or indirect effects on the cccDNA. Several investigational direct acting antivirals and host targets
that are implicated in HBV lifecycle are currently under investigation with the hope of achieving a cure. CRISPR
screens have emerged as robust tools to discover host restriction and host dependency factors across multiple
viral families and druggable genes provide information for the development of novel host-targeting therapeutics.
HBV is exclusively a hepatotropic virus that infects only human hepatocytes and for studies that aim to
characterize host responses primary human hepatocytes are the only cells for such studies. In parallel, the main
target primary cell types for HIV are CD4+ T cells. Co-culture systems that incorporate these primary cell types
are optimal for understanding the crosstalk between HIV and HBV infected cells and characterize host factor
changes at the gene and protein level. Our robust and innovative co-culture systems provide unique
opportunities to study HIV/HBV co-infections. These, together with a series of rigorous and analytical methods
spanning from CRISPR screens in primary cells to proteomics, phosphoproteomics and secretomics approaches
will be used here for the discovery and validation of host factors and antivirals against HIV/HBV co-infections
with the potential to generate therapeutics for a functional HBV cure.

Public health relevance
Project Narrative HIV co-infection accelerates liver cirrhosis and liver cancer in chronic hepatitis B virus (HBV) carriers. The use of primary cell culture models together with unbiased and targeted functional genomics and proteomics approaches will determine host proteins that are induced or suppressed under co-infection conditions and in response to antiviral treatment. These studies will provide information for developing novel antiviral strategies that may lead to a functional HBV cure.